Regulation of chromatin organization and dynamics by INO80

Summary
We know very little about the mechanism of INO80, how it disrupts nucleosomes and the factors governing its
activity. We will take detailed “snapshots” of INO80 during nucleosome remodeling to find how INO80 and
nucleosomes are moved during remodeling. A series of orthogonal approaches will be used to arrest INO80
remodeling at distinct stages and examine conformational changes in the core nucleosome and INO80. We will
build on our recent observations of the motor domain being engaged at the H2A-H2B interface and persistently
displacing DNA from this surface to find why displacement occurs, the factors that control displacement and
whether this displacement weakens the interactions of H2A or H2A.Z dimers with the rest of the histone octamer
or otherwise disrupts the nucleosome structure. Based on the proximity of Arp5 to nucleosomal DNA, we will test
the premise of Arp5 as the “gatekeeper” regulating DNA traversing through the center of nucleosomes with wild
type INO80 and mutant Arp5 in which either its histone or nucleosome binding regions have been deleted or
mutated. We will also test whether the Arp8 module regulates Arp5 interactions with the acidic pocket of
nucleosomes or nucleosomal DNA and if communication between these two domains is mediated by the Ino80
catalytic subunit. INO80 will be arrested at different stages in remodeling by limiting DNA translocations to
specified distances, arresting with non-hydrolyzable ATP analogs, limiting linker DNA length and mutation of
Arp8 and Arp5. We will probe the role of DNA sequence in INO80 remodeling because we observed coupling of
ATPase activity to nucleosome movement being dramatically affected by the DNA sequence of the core
nucleosome. We will find as suggested in these experiments if INO80 interactions and conformation varies
depending on the DNA sequence bound by nucleosomes. In order to better examine the importance of DNA
sequence in a “native” context, we will use yeast chromatin reconstituted with recombinant histones and
simultaneously examine the differences of INO80 binding and remodeling with many thousands of nucleosomes,
each with a different DNA sequence. We will use our expertise of mapping protein-DNA interactions in these
genomic assays to sort with high precision the interactions of the INO80 subunits along with nucleosome
movement, composition and structural features at ~bp resolution to provide a detailed analysis of each of these
nucleosomes in a time resolved manner when remodeled. This approach will provide more insights into the DNA
sequence specificity of INO80 and if there are “hot spots” for mobilizing/ destabilizing nucleosomes or
exchanging H2A.Z in the yeast genome that doesn’t require additional factors. To confirm if INO80 behaves the
same in vivo as in our in vitro assays, we will transfer several of these approaches to yeast cells so that we can
measure chromatin dynamics in vivo with the same resolution as in vitro. We will compare how mutations in Arp5
and Arp8 change nucleosome dynamics in vivo, the importance of genomic position, and other factors for INO80
remodeling not present in our yeast reconstituted chromatin.

Public health relevance
Narrative The large multi-subunit INO80 ATP dependent chromatin remodeler regulates gene expression, DNA replication, and chromosome integrity; and alterations of these complexes are often found to be the cause of different human diseases such as cancer, coronary and other vascular diseases. Our focus is on understanding the mechanism whereby the INO80 chromatin remodeler disrupts nucleosome structure and changes nucleosome composition and the factors including DNA sequence that regulate these changes. In this proposal we also develop an innovative approach of quantitatively measuring nucleosome dynamics in vivo with unprecedented high resolution.